CORE--RESEARCH DEVELOPMENT/ENRICHMENT

The broad, long-term objectives of this Research Development/Enrichment Core are to enhance the quality of currently supported research; to build upon already established initiatives of junior faculty development and to stimulate and facilitate new research on fundamental mechanisms of the biology of aging. Research Program areas address musculoskeletal frailty, signal transduction, and protein integrity. The primary target group of the Core includes junior faculty, senior faculty who are new to gerontology, and research trainees, as well as the established gerontologists among our faculty. The specific aims are to establish each of the following; (1) a series of Research Workshops which emphasis the bridging of gerontology and discipline-specific molecular and cell biology; (2) a Pilot Research Grants Program in collaboration with a NIA-supported Pepper Center; and (3) a Minority Visiting Scholars Program. Research workshops will integrate annual progress at the cutting edge of molecular and cell biology of relevance to the Center Research Resource Cores into the gerontological context of the Center Research Program Areas. Pilot Research Resource Cores into the gerontological context of the Center Research Program Areas. Pilot Research Grants will support novel molecular and cellular studies of relevance tot he Center Research Program Areas or Research Resource Cores. The Minority Visiting Scholars Program will enable long-term access of successful applicants from the national community of minority scientists to all Center resources and activities.